HIV persistence and treatment response in Kaposi sarcoma

PROJECT SUMMARY
Kaposi sarcoma herpesvirus (KSHV) is the etiologic agent of Kaposi sarcoma (KS), which causes significant
morbidity and mortality worldwide, particularly in people with HIV (PWH) and in sub-Saharan Africa (SSA) where
KSHV seroprevalence is high. It is estimated that 80% of the KS burden in SSA, where the impact of KS is
heaviest, is attributable to HIV infection. In our prospective KS cohort in Uganda (the “HIPPOS” study), we have
observed that outcomes remain poor despite optimized treatment with antiretroviral therapy (ART) and
chemotherapy, with an overall 1-year survival of 64% among the first 200 study participants. However, we have
observed differential outcomes among participants, with 11% achieving a clinical complete response, 48% a
partial response, 13% experiencing stable disease, and 25% progressive disease. Identifying the factors that
contribute to these differences in outcome could inform the design of more effective KS therapies.
Our ongoing studies of the HIPPOS KS cohort and findings from other investigators suggest that control of HIV
is an important factor in KS response. First, among the initial 200 participants in our HIPPOS cohort, higher
baseline plasma HIV viral loads were independently associated with increased mortality in HIV-associated KS.
Second, RNA sequencing of pre-treatment KS tumors demonstrated high-level expression of HIV genes in KS
tumors from PLWH. Third, transcriptionally active HIV and HIV Nef protein have been identified in treatment-
refractory KS tumors, suggesting that KS tumors could be a reservoir for HIV that shapes the KS tumor
microenvironment. Fourth, our studies of several KS cohorts have identified CD8+ T-cells specific for peptides
derived from the HIV Gag/Pol, Vpr, and Nef gene products that persist in both KS tumors and peripheral blood
of PWH with KS despite peripheral HIV suppression with ongoing ART. Collectively, these findings suggest that
persistence of HIV in KS tumors of PWH might make an important contribution to treatment resistance.
In this proposal we will test the hypothesis that intratumoral HIV persistence is associated with treatment
resistance in PWH with KS through evaluation of: (i) HIV, KSHV, and host gene expression, and (ii) HIV and
KSHV protein expression in serially acquired tumor biopsies from cohorts of PWH enrolled in three prospective
KS therapeutic clinical trials. The first cohort comprises the HIPPOS study of newly diagnosed adults with KS
treated with either bleomycin/vincristine or paclitaxel at the Uganda Cancer Institute in Kampala, Uganda. The
second and third cohorts comprise adults with KS enrolled on two trials conducted by the NCI-sponsored Clinical
Immunotherapy Trials Network (CITN) who were treated with a human IL-7 agonist (trial CITN-17) or with the
PD-1-specific monoclonal antibody pembrolizumab (trial CITN-12). Central to all three clinical trials is the
hypothesis that control of KSHV and HIV replication by KSHV- and HIV-specific T-cells combined with effective
ART is essential for KS regression and resolution. The successful completion of these studies will contribute to
improved outcomes for individuals with KS worldwide.

Public health relevance
PROJECT NARRATIVE Kaposi sarcoma-associated herpesvirus (KSHV) is a virus found throughout the world that can cause a type of cancer called Kaposi sarcoma (KS), particularly in people who are also infected with HIV. KSHV infection is most common in sub-Saharan Africa, where it is a frequent cause of cancer-related death. The studies proposed in this application will investigate how HIV may hide in KS tumors and contribute to treatment resistance of KS.